Development of a point of care test-strip kit to quantify breastmilk nutrient profile

PROJECT SUMMARY
Breast milk provides numerous health benefits for infants including reduced illnesses such as otitis media, respiratory and
gastrointestinal infections, asthma, sudden infant death syndrome, and a reduction in the likelihood of obesity and diabetes.
It is the standard of care for NICU infants. The American Academy of Pediatrics (AAP), World Health Organization
(WHO), and Center for Disease Control and Prevention (CDC) recommend exclusive breastfeeding the first 6 months and
ideally until age 2. Breastmilk alone is not adequate to meet the needs of very low birth weight (VLBW) infants due to the
high variability amongst mothers and higher needs of VLBW preterm neonates and infants. Therefore, human milk fed to
preterm infants requires fortification (supplementation) with nutrients. Standard fortification involves adding a fixed amount
of fortifier per 100ml of human milk and is the most utilized fortification method in the US. The fixed amount is determined
by the manufacturer of the human milk fortifier and assumes that all human milk contains the same amount of protein
and other macronutrients. These assumptions of the macronutrient composition of human milk have been shown to
underestimate the amount of protein a neonate and infant in the NICU is receiving and can lead to poor neurocognitive
outcomes. Therefore, a rapid point of care test for macronutrient and micronutrient concentrations in breast milk is
imperative for improving infant nutrition and essential for targeted fortification.
We present an easy-to-use device that includes a test strip coupled with our smartphone application to rapidly quantify
macronutrients in human milk. These results will help a health care provider determine the fortification based on
actual values and decrease conjectures for macronutrient composition of a milk sample, providing optimal targeted
nutrition for the most vulnerable NICU patients. Further, the rapid point of care macronutrients test will change the
workflow for failure to thrive and slow growth infants. Our device will allow for rapid and accurate diagnosis in the clinic
and warrant more immediate referral to pediatric specialists e.g., if the caloric value of a sample is tested then there may be
immediate confirmation of caloric intake for the work-up of failure to thrive infants.
Successful completion of the proposed Phase I program will provide critical data to expand development of our one-of-a-
kind technology in a Phase II program that will be geared towards validation in a large clinical study. This study will include
further development of easy-to-use point of care tests in human milk and demonstrate the use of our test strip as an easy
tool to integrate into NICU workflow enabling a custom electronic health record-friendly software to allow for our test strip
results to be analyzed and facilitate targeted fortification and family integrated therapy.

Public health relevance
PROJECT NARRATIVE Human milk is lifesaving in the NICU, however, for very low birth weight (VLBW) infants’ human milk alone does not provide sufficient nutrition and it is standard practice to fortify human milk for VLBW infants. The standard practice is to add a fixed amount of fortifier per 100ml of human milk. The fixed amount is determined by the manufacturer of the human milk fortifier assuming that all human milk contains the same amount of protein. Standard fortification does not solve the problem of protein undernutrition in VLBW infants. Targeted fortification improves outcomes and growth but is limited by no rapid point of care test available to quickly quantify the macronutrient composition of human milk. We present an easy-to-use test strip device coupled with our smartphone application to rapidly quantify macronutrients. The Macronutrient Breast Milk Test Strip and associated smartphone application (Emily smart application) is an analytical system that uses an enzyme-based test strip, and a smartphone camera and application as a spectrometer. This Phase I SBIR proposal will demonstrate human milk quantification that will allow for the fortification of human milk, thus ensuring that VLBW newborns receive the nutrients they require.